Continuing Education for Structural Biology Mentors

PROJECT SUMMARY/ABSTRACT
The structural biology and molecular modeling market is expected to reach USD 18.1 Billion with a Compound
Annual Growth Rate (CAGR) of 17.1% during the forecast period of 2022-2028 which has the potential to drive
substantial demand for a workforce of the future. While the significance of advancement in cutting-edge Cryo-
EM data processing to improve and accelerate drug discovery to treat diseases is driving innovation and
economic growth and happening in the pharma industry, many structural biology investigators and would-be
investigators are caught without the enhanced research training to use rapidly evolving and sophisticated
computational tools, including AI and deep learning tools, proficiently to help the pharma industry accelerate
drug discovery for society. Underrepresented minority (URM) representation in cutting-edge biomedical research
fields is not expected to be higher than what was reported in a 2019 NSF survey, which showed URM as a
percentage of the academic doctoral workforce at 8.9%, or a 2021 AAMC report which found diversity for URM
at academic leadership ranks in American academic medical colleges at about 5.8%. In particular, the high costs
associated with Cryo-EM research present a significant barrier for smaller institutions like Minority Serving
Institutions (MSIs) and Historically Black Colleges and Universities (HBCUs) to train their students for the
structural biology-based biomedical career of the future.
To address these challenges, the Structural Biology Grid (SBGrid) Consortium at Harvard Medical School and
Meharry Medical College, an HBCU, will extend their existing partnership to improve diversity and deliver an
enhanced research training program across the entire community for structural biology investigators on the
current Cryo-EM data processing workflow that includes AI components, necessary skills, knowledge, and best
practices to help them stay on top and be productive in their careers in the biomedical research workforce.
Additionally, the program is designed not just to impart training for the principal investigator participants but also
to increase sustainability and scalability by enabling them with an evidence-based, integrated gear of data
science training model and system for structural biology comprising a complete set of training program material
with training datasets, a collection of structural biology data analysis and visualization software, and a
sustainable training and computing environment with supporting resources that they could use in their home
institutions to provide continuing education and longitudinal mentoring to their laboratory members and students
who are pursuing next-generation biomedical careers in structural biology.

Public health relevance
PROJECT NARRATIVE Cryo-EM data processing for structural biology improves and accelerates drug discovery that treats diseases and is driving innovation, economic growth, and happening in the pharma industry. Our proposed continuing education program aims to develop a portable continuing education solution with integrated data, software, workflow, and a sustainable computing environment that trains diverse cohorts of structural biology investigators to strengthen their Cryo-EM data processing skills, as well as enables them with a training solution that they could adapt and use in continuing education programs in Cryo-EM data processing at their home institution or local community. This enhanced research training program will have the potential to provide and scale sustainable continuing education in Cryo-EM data processing to a diverse group of individuals for a biomedical career of the future.